Determining the role of intratumoral dendritic cells in anti-tumor immunity

PROJECT SUMMARY Conventional dendritic cells (cDCs) are central regulators of the adaptive immune response, and as such are necessary for T cell-mediated cancer immunity. In particular, anti-tumoral responses are induced by a specialized subset of cDCs (cDC1) that transport tumor antigens to draining lymph nodes and cross-present antigen to activate cytotoxic T lymphocytes. Less clear is the role of cDCs within the tumor microenvironment, but in general these intratumoral cDCs have been described as immature, tolerogenic, or even immunosuppressive, suggesting that the functionality of cDCs may be a critical barrier to sustaining cytotoxic T cell responses. We have recently described expression of TIM-3 (T-cell immunoglobulin and mucin domain containing-3) on cDCs in human and murine mammary tumors, and found that treatment with αTIM-3 antibodies improved response to standard-of-care paclitaxel chemotherapy in murine models of triple- negative and luminal B disease. This improved response was dependent upon CD8+ T cells, despite the near absence of TIM-3 expression on this population either prior to or during therapy. However, gene expression analysis identified upregulation of Cxcl9 within intratumoral DCs during combination therapy, leading to the central hypothesis for this proposal that TIM-3 blockade can indirectly promote cytotoxic T cell activity by enhancing cDC functionality. In order to address this hypothesis, I propose to determine how TIM-3 blockade alters the activation/functional state of cDC1s (Aim 1) and determine the functional relevance of cDC1s during TIM-3 blockade (Aim 2). As early phase clinical trials combining PD-1 and TIM-3 blocking antibodies have not shown improved efficacy, results from these studies may help determine how TIM-3 blocking antibodies should optimally be utilized in the clinic. !

Public health relevance
PROJECT NARRATIVE Breast cancer remains 2nd among cancer-related deaths of women in the US, and as such identifying effective treatment options and improving upon standard-of-care therapies is of critical importance. In recently published data, we have observed expression of TIM-3 on conventional dendritic cells in human and murine mammary tumors, and found that treatment with anti-TIM-3 antibodies improved response to standard-of-care paclitaxel chemotherapy in murine models of triple-negative and luminal B disease. The proposed research would elucidate the functional changes that occur in conventional dendritic cells as a result of treatment with anti-TIM- 3, and may help determine how TIM-3 blocking antibodies can best be used clinically.